Mechanism of cardioprotective mitochondrial oxidative stress priming in doxorubicin-induced cardiotoxicity

PROJECT SUMMARY
Mitochondria are essential for life because of their role in energy production and signaling functions that control
redox homeostasis, inflammatory responses, and cell death. Accordingly, there is abundant evidence that
mitochondrial dysfunction and oxidative stress drive cardiovascular disease pathogenesis, yet no mitochondrial
or antioxidant therapies currently exist. Exposing mitochondria to some forms of stress initiates cytoprotective
signaling programs that result in beneficial adaptations, a phenomenon called “mitohormesis”. Multiple benefits
of mitohormesis have been documented including increased lifespan in invertebrate model organisms and,
relevant to this proposal, protection against drug-induced liver injury through preservation of mitochondrial
function in mice. However, how mitohormetic signaling functions in the heart has not been investigated.
Therefore, the project goal is to test the potential for mitohormesis to protect against cardiac pathology and to
identify the underlying signaling pathways through which it functions. Our lab has developed the first mouse
model of oxidative mitohormesis, a form of mitohormesis that occurs in response to transient mitochondrial
oxidative stress. These mice allow for inducible and reversible accumulation of superoxide, a form of
mitochondrial reactive oxygen species (mtROS). Superoxide exposure only during embryogenesis results in
mitohormesis in adult mouse liver characterized by increased basal antioxidant gene expression and
mitochondrial biogenesis, and our preliminary data show the same is true in adult heart tissue. In addition, using
a mouse embryonic fibroblast model of oxidative mitohormesis, transient mtROS exposure results in adapted
cells that are protected against doxorubicin (DOXO)-induced oxidative stress and cell death. However, the
mechanism driving this sustained protection is unknown. Mitochondrial superoxide inactivates the tricarboxylic
acid cycle enzyme aconitase, leading to accumulation of its substrate citrate. Citrate can then be converted to
acetyl-CoA, which is used for histone acetylation. In this proposal, I will test the central hypothesis that oxidative
mitohormesis will protect against DOXO-induced cardiotoxicity (DIC), and that mitochondrial citrate mediates
epigenetic remodeling that drives this adaptive signaling response. Since the cardiac toxicity of DOXO is
mediated by increased mtROS production and decreased mitochondrial biogenesis, Aim 1 will determine if
oxidative mitohormetic signaling can protect the heart in a chronic model of DIC. Aim 2A will uncover the
mechanism by which the mitochondrial metabolite citrate regulates epigenetic-mediated changes in nuclear gene
expression in response to oxidative mitohormesis, while Aim 2B will test whether citrate is sufficient to induce
mitohormesis and protect against DIC in vivo. The long-term goal is to determine how mitohormetic signaling
affects the response of cardiac tissue to oxidative and mitochondrial injury, a deeper understanding of which
may uncover novel metabolites and signaling pathways with therapeutic potential for cardiac pathology and
cardiovascular aging.

Public health relevance
PROJECT NARRATIVE Disruption of mitochondrial function and increased mitochondrial oxidative stress results in doxorubicin-induced cardiotoxicity, but there are currently no preventative strategies or treatments for this pathology. Mitohormesis is a novel form of adaptive mitochondrial priming to stress that prevents aging in invertebrates and protects against drug-induced liver injury in mice, but how this signaling functions in the cardiovascular system is unknown. This project aims to test how oxidative mitohormesis, a specialized pre-conditioning to mitochondrial oxidative stress, affects the response of heart tissue to anthracycline cardiotoxicity and to define the molecular mechanisms involved.